Strengthen regulatory systems to ensure the safety and quality of food and medical products.

RFA-FD-18-022: Project Summary/Abstract
Strengthen Regulatory Systems to Ensure the Safety and Quality of Food and Medical
Products (U01)
The project’s overall long-term goal is to strengthen global regulatory systems to ensure the
safety and quality of food and medical products. The project aims to achieve three research
objectives: 1) develop global norms and standards; 2) articulate evidence- and science-based
policy options, including those relating to regulatory systems and regulatory systems
performance; and 3) provide technical, scientific, and research-based support to national
regulatory authorities and governments through systems strengthening efforts. The research
project seeks to build upon and expand well-established collaborations between the WHO and
FDA, aligned with mutual global goals on product safety and quality and better and more
secured product supply chains. This is critical for achieving the health-related Sustainable
Development Goals and other targets set by the global health community. As the international
authority on public health, WHO is tasked to lead and coordinate global action to strengthen drug
and food regulatory capacities. In line with the Funding Opportunity Announcement, WHO
proposes the following activities under the three aforementioned research objectives; 1) Aligned
with Objective 1, developing norms and standards; Aligned to Objective 2, tackling substandard
and falsified medical products; and Aligned to Objective 3, ensuring food safety. The project will
be implemented over 60 months, through 12 month phases; managed and implemented by
project management and technical staff at WHO, with key relevant stakeholders such as
ministries of health, national regulatory authorities, and others as required. WHO draws on a
wide international network of partners and contacts, including WHO Collaborating Centres,
NGOs, and National Professional officers. With regulatory systems strengthening as an
international priority, increasingly complex global regulatory environments for food and medical
products, and requests from countries for support to strengthen their ability to ensure access to
safe and quality products is prompting WHO to shift the paradigm and embark on a novel
science-based opportunities for public health collaboration and research development. This
approach will contribute to the regulatory knowledge base and fill the gaps in research, public
health and scientific efforts. Strong political support from global health agencies/partnerships,
and collaborative efforts with the US Food and Drug Administration is crucial in this respect.

Public health relevance
RFA-FD-18-022: Project Narrative Strengthen Regulatory Systems to Ensure the Safety and Quality of Food and Medical Products (U01) Data-driven and science-based research and innovation are vital to assure the quality and safety of medical products and foods, key elements of achieving the health-related Sustainable Development Goals and other targets set by the global health community. The international authority on public health, WHO aims to advance and expand efforts to strengthen global regulatory systems for foods and medical products and proposes to continue collaborative efforts with the US Food and Drug Administration in support of this goal.